High throughput functional annotation of the impact of human UTR sequence variation on gene function and protein output

SUMMARY
Sequencing studies have identified a large set of variants in the human genome, the majority of which fall outside
protein coding sequences. Decoding the significance of these variants in gene function represents a major
challenge. Untranslated regions of mRNAs play an important role in gene regulation, and single nucleotide
changes in these regions can have remarkable effects on protein expression and gene function. The goal of this
proposal is to develop new and generalizable genomic and computational approaches to understand the
functional effect of genetic variation in the 5’ and 3’ UTRs and its impact on protein output and gene function.
We propose two aims to achieve this goal. First, we will identify all the variants in the human 5’ and 3’ UTRs,
characterize their conservation and association with disease, and develop a high throughput parallel method
(NaP-TRAP-seq) to quantify the regulatory activity of each variant on mRNA translation and protein output across
different cell types (Aim 1). This aim will generate extensive quantitative data for the effect of each UTR variant
on protein output. Second, we will develop a computational model to predict the impact of each variant on protein
output and develop a new constraint model to analyze how variant conservation relates to the effect on protein
output and translation (Aim 2). This model will predict the functional effects of known and novel variants on the
translation of the downstream coding sequence and how sequence variants affect gene function. Together, these
aims will provide a generalizable method to understand the regulatory significance of each variant in the UTR,
will provide the principles to interpret variants of uncertain significance in the UTR, and will help predict the
functional consequences of sequence variants across trait- and disease-associated genes.

Public health relevance
NARRATIVE Sequencing studies have identified variants in the human genome among healthy and diseased individuals. A major challenge is to understand the significance of these variants in gene function. This proposal aims to decode the regulatory information present in untranslated regions of mRNA to understand how variation in the 5’ and the 3’ UTRs regulates protein output to influence disease- and trait-associated phenotypes.